IGF::OT::IGF Evaluating & Correcting for Response Bias across versions of the Medicare Health Outcomes Survey.

Evaluating & Correcting for Response Bias across versions of the Medicare Health Outcomes Survey.